Molecular engineering and systematic evaluation of bispecific aptamers to develop potent and efficacious therapies for the immunomodulation of Non-Small Cell Lung Cancer

PROJECT SUMMARY (This document is from the Parent submission)
Cancer is set to bypass cardiovascular disease as the number one cause of death in United States and it is a
leading cause of death worldwide. Non-Small Cell Lung Cancer (NSCLC) is a major contributing factor to this
statistic. Recent advancements in chemotherapeutic delivery and the development small molecule inhibitors,
such as tyrosine kinase inhibitors, have been indispensable in decreasing disease prevalence and burden.
Additionally, the recent FDA approvals of immunomodulating therapies, such as immune checkpoint inhibitors
(ICIs), chimeric antigen receptor (CAR) T cells, and bispecific antibodies, emphasizes the importance that
immune system evasion plays in disease progression and relapse. Unfortunately, administration of
these targeted and immunomodulating therapies is often met with tumor acquired resistance (e.g.,
secondary mutations; T cell exhaustion) and incites non-specific or on-target/off tumor side effects (e.g.,
immune related adverse events). This suggests a need for alternative or adjuvant NSCLC therapies that are
not only potent and efficacious but exercise a wide therapeutic index. We propose to exploit aptamer
technology as one potential way to address this need. Aptamers are single strand oligonucleotides that
bind to their targets with high specificity and affinity and their relative lack of immunogenicity as a foreign
substance, compared to antibodies, make them ideal reagents to modulate the immune system.
Furthermore, their ease of manipulation makes molecular engineering to design and optimize such reagents
relatively straightforward. Our goal is to develop novel immunomodulating bispecific aptamers (bsApts) that
dually bind to immune cell CD3ε and NSCLC tumor associated antigens (TAAs) to induce formation of
effective immune synapses. We propose to use molecular engineering techniques to rationally design bsApts
and systematically evaluate specific bsApt properties, such as (i) valency, (ii) affinity, and (iii) linker length/
type in their ability to induce artificial immune cell activation in vitro and anti-tumor responses in vivo. We also
propose to take a transcriptomics approach to better understand how designs/targets affect tumor
heterogeneity, tumor infiltrating lymphocyte phenotypes, and off-target immune cell activation. Secondary
goals look at improving pharmacokinetic properties that limit bsApt clinical translatability while long-term
goals look to generalize our findings on these properties to current and future bispecific therapies that target a
wide range of solid and hematological cancers.

Public health relevance
PROJECT NARRATIVE (This document is from the Parent submission) Lung cancer is a leading cause of death worldwide and poses a significant physical, mental, emotional, and financial burden on patients and their families. Over the last decade there has been an increased prevalence of immunomodulating therapeutics to treat lung cancer, defining the immune systems role, or lack thereof, in disease progression and relapse; however, dose limiting adverse events and tumor resistance mechanisms still limit these reagents potency and efficacy, and thus, their ability to reduce disease burden. We propose to exploit bispecific aptamer technology to develop alternative or adjuvant therapeutics and understand what molecular design properties drive the induction of the greatest anti-cancer response.